Development of a novel liver-specific positron emission tomography tracer

PROJECT SUMMARY
Liver diseases affect nearly 4.5 million individuals in the United States. Clinicians utilize various imaging
modalities (ultrasound, computed tomography, magnetic resonance imaging) to assess liver structure and
presence of liver cancer. These modalities have a high degree of accuracy for identifying and characterizing
liver cancer within the liver. However, the current imaging techniques lack the sensitivity for detecting
metastatic tumors outside of the liver. Timely detections of these metastatic lesions have significant clinical
implications relating to surgical management or liver transplantation.
We have developed a liver-specific PET tracer which we hypothesize would provide a higher sensitivity for
detecting tumors at a smaller size compared to the currently used imaging modalities. We anticipate that this
tracer will also have non-oncologic applications such as assessment of liver function and biliary tract
pathology. In this proposal, we aim to complete the preclinical testing and investigational new drug (IND)-
enabling studies in preparation for first-in-human clinical trials.

Public health relevance
PROJECT NARRATIVE Imaging is a critical aspect of management of liver cancers; however, the current modalities have inherent limitations. We aim to develop a more sensitive approach for detecting metastatic liver tumors.